Integrin/TGF-beta Axis in Tubulointerstitial Fibrosis

DESCRIPTION (provided by applicant): Our goal is to analyze the molecular mechanisms that underlie the formation of tubulointerstitial (TI) fibrosis, to devise more effective therapies to prevent its progression. We study the collagen receptor integrins α1β1 and showed that it downregulates collagen synthesis, and its loss leads to increased glomerular fibrosis following injury. Integrin α1β1 plays an anti-fibrotic action by negatively regulating the phosphorylation state of pro-fibrotic growth factor receptors via activation of the tyrosine phosphatase TCPTP. We have also found that integrin α1β1 is a negative regulator of TI fibrosis, as integrin α1KO mice show increased unilateral ureteral obstruction-induced fibrosis. Moreover, integrin α1KO collecting duct (CD) cells have increased activation of TGF-β receptor (TβR)-dependent pro-fibrotic signaling, such as phosphorylated Smad3 and collagen levels. TGF-β exerts its functions via activation of the serine/threonine kinases TβRI and TβRII. Binding of TGF-β to TβRII leads to phosphorylation of TβRI and subsequent activation of the major pro-fibrotic mediator Smad3. Interestingly, the cytoplasmic tail of TβRII can also be phosphorylated on tyrosine residues. However, whether these tyrosines play any physiological or pathological role in renal cells is unknown. The novelty of this proposal is that integrin α1KO CD cells show increased basal levels of tyrosine phosphorylated TβRII. This result suggests that, in renal cells, integrin α1β1 crosstalks with TβRII and it might prevent its pro-fibrotic action by downregulating its tyrosine phosphorylation levels. Interestingly, inhibition of TCPTP in CD cells leads to increased Smad3 activation and collagen synthesis. This result, together with the finding that 3 tyrosines in the TβRII tail can be potential substrates of TCPTP, forms the hypothesis that integrin α1β1 negatively regulates TβRII tyrosine phosphorylation via activation of TCPTP. Thus, we propose that integrin α1β1/TCPTP-mediated dephosphorylation of TβRII represents an important, but previously undescribed mechanism to selectively reduce TβRII activation and consequent progression of fibrosis. To test this hypothesis: Aim 1 will analyze the role of TβRII-mediated pro-fibrotic signaling in TI injury in the integrin α1KO mice. We will cross integrin α1KO mice with global null or floxed Smad3 mice to determine if preventing TβR/Smad3 axis in the collecting system is sufficient to ameliorate TI fibrosis in the α1KO mice. We will then determine if in vivo activation of TCPTP is beneficial in the setting of TI injury by counteracting TβR-mediated pro-fibrotic action. Aim 2 will determine the mechanisms whereby integrin α1β1 negatively regulates TβRII. We will use in vitro approaches to analyze i) if TCPTP directly binds and dephosphorylates TβRII; ii) if tyrosine residues are important to control TβRII-mediated Smad3 activation and collagen synthesis; and iii) which tyrosine(s) controls TβRII-mediated functions. This study will lead to the identification of a novel crosstalk between integrin α1β1 an TβRII and, most importantly, a novel mechanism whereby TβRII-mediated pro-fibrotic signaling can be negatively modulated.

Public health relevance
PUBLIC HEALTH RELEVANCE: Transforming growth factor-β (TGF-β) is widely recognized as one of the key mediators of renal fibrosis leading to chronic kidney disease (CKD); however anti-TGF-β therapy is not effective for the treatment of CKD because 1) TGF-β also exerts beneficial effects; and 2) activation of TGF-β downstream pro-fibrotic signaling can be TGF-β ligand independent. In this proposal, we provide evidence that in the collecting system of the kidney, the collagen receptor integrin α1β1 crosstalks with the TGF-β receptor II (TβRII) and plays an anti-fibrotic role by negatively regulating TβRII-mediated pro-fibrotic signaling in a ligand independent fashion. Understanding how integrin α1β1 negatively controls TβRII pro-fibrotic action will contribute to the identification of 1) a novel crosstalk between integrin α1β1 and TβRII; 2) a novel mechanism whereby TβRIImediated pro-fibrotic signaling can be negatively modulated; and 3) areas where integrin and/or TβRII functions can be specifically targeted to halt and ideally prevent CKD.